Structural basis and physiological consequences of alpha-Synuclein binding to neurexin 1beta

Project Summary/Abstract
α-Synuclein is a small, soluble neuronal protein that is the primary component of the Lewy body aggregates
that are the hallmark of Parkinson's disease. While the mechanistic details are not yet well-understood,
emerging evidence suggests that cell-to-cell transmission of toxic forms of α-Synuclein is the basis of disease
propagation. Our lab has recently identified complex N-linked glycans as mediators of cellular internalization of
both monomer and aggregate forms of α-Synuclein bearing an N-terminal acetyl group, a physiological
modification of the protein. We specifically identified the neuronal glycoprotein neurexin 1β as capable of
driving internalization of α-Synuclein in a glycan-dependent manner. The goal of our proposed research is to
characterize the structural basis of α-Synuclein binding to neurexin 1β, the role of both N-terminal acetylation
and glycosylation in conferring specificity in this interaction, and determine the molecular mechanisms resulting
cellular internalization of α-Synuclein following binding neurexin 1β. Our hypothesis is that cell-to-cell
transmission of αS is dependent on interactions with neurexin 1β and that the selectivity in these interactions is
dependent on transient structural changes in α-Synuclein conferred by the N-terminal acetyl group. To
investigate this hypothesis, we have developed three specific aims with the following goals: determine the
structural features of α-Synuclein bound to neurexin 1β, including defining a minimal α-Synuclein construct
required for binding (Aim 1); determine the mechanisms by which binding to neurexin 1β results in cellular
internalization of α-Synuclein (Aim 2); and understand the functional impact of α-Synuclein binding to neurexin
1β (Aim 3). To achieve these goals, we will carry out in vitro coarse grain and high resolution structural
characterization of α-Synuclein:neurexin 1β complexes and use live-cell imaging to quantify internalization of
α-Synuclein and the ability of internalized α-Synuclein to seed aggregation of endogenous α-Synuclein. We
will contrast WT monomer, PD-associated point mutants and fibrillar forms of α-Synuclein. Through this
research we expect to characterize key interactions involved in propagation of α-Synuclein pathology in
Parkinson's disease, as well as to gain insight into the structural features of α-Synuclein:neurexin 1β
complexes. Ultimately, the characterization of α-Synuclein: neurexin 1β interactions carried out through our
studies may provide a new target for Parkinson's disease treatment and serve as the basis identifying novel
small molecule therapeutics.

Public health relevance
Project Narrative The aggregation of proteins such as α-Synuclein into fibrillar aggregates plays a pivotal role in the progression of Parkinson's Disease and related neurodegenerative disorders. The proposed research will study the molecular and cellular factors related to cell-to-cell transmission of toxic α-Synuclein species to gain insight into the mechanism of disease propagation.